Project-002

Project Abstract
As a highly complex and multifactorial condition, chronic low back pain (cLBP) greatly contributes
to disability, opioid use disorder, and negatively impacts quality of life. Previously supported by
the HEAL Initiative’s BACPAC consortium, the University of Pittsburgh Mechanistic Research
Center (LB3P) has gathered unprecedented and comprehensive data on clinical, biological,
biomechanical, and behavioral characteristics from over 1,000 cLBP participants with impressive
one-year follow-up, as well as from persons without low back pain. This landmark work by a
transdisciplinary collaborative team of investigators has led to the creation of large datasets and
novel preliminary phenotypes that illuminate the multi-dimensional nature of cLBP and help
predict treatment responses. Importantly, BACPAC research has laid the groundwork for
achieving comprehensive phenotyping of cLBP by integrating deep phenotyping datasets into a
theoretical model of LBP, facilitating a precision medicine approach. However, significant
knowledge gaps remain, particularly regarding how the phenotypes of this chronic condition
change over time and how they relate to other chronic overlapping pain conditions (COPCs) and
common musculoskeletal (MSK) disorders, which can severely impact treatment outcomes and
the pain experience. By leveraging the successful infrastructure and existing cohorts achieved
through BACPAC, we aim to deepen our understanding of the key features associated with the
overall experience of cLBP to promote whole-person health. To this end, we propose the following
specific aims: (1) determine the evolution of whole person pain characteristics in cLBP
individuals and (2) validate, refine and augment cLBP models to include longitudinal data,
COPCs, and other MSK conditions, and perspectives and outcome preferences from
people with lived experiences and health disparities to guide patient-centered precision
medicine approaches to non-addictive treatments of pain. This will be achieved by leveraging
existing collaborations within HEAL-funded programs including experts in other pain conditions to
supplement our unprecedented interdisciplinary team for thorough assessment of a large chronic
low back pain longitudinal cohort, supporting the INTERACT Initiative. This work will also leverage
the commitment from external collaborators to bring the field together to understand the whole
person experience of pain with unparalleled levels of breadth and depth of phenotyping features
and clinically applicable models, creating a unique opportunity to significantly impact care for
persons experiencing chronic pain.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the NIH HEAL Initiative because it will expand longitudinal data collection and analysis within an existing large chronic lower back pain (cLBP) cohort and evaluate the contributions of other pain conditions. The research is relevant to the public by acquiring vital information to better understand whole person experience of pain that includes cLBP and other chronic overlapping pain and other common musculoskeletal conditions, and perspectives from people with lived experiences. Successful completion of the proposed research will allow for patient-centered precision medicine approaches to non-addictive treatments of pain.